Control of cell number in developing retina

DESCRIPTION (provided by applicant): The long-term scientific goal of my laboratory is to understand the molecular mechanisms that specify retina cell number. Using the compound eye of Drosophila as an experimental model, my laboratory has discovered a novel signaling pathway, the Hippo pathway, which controls retina cell number by coordinately regulating cell proliferation and cell death. Work from my laboratory in the last project period has allowed us to delineate a Hippo kinase cascade comprised of the Ste20-like kinase Hippo (Hpo), the NDR family kinase Warts (Wts), and the transcriptional co activator Yorkie (Yki). Hpo phosphorylates and activates Wts, which in turn, inactivates Yki by phosphorylating the latter at a critical residue (S168) and excluding it from the nucleus, where it normally functions as a co activator for the TEAD/TEF family transcription factor Scalloped (Sd). The Hippo pathway promotes cell death and restricts cell proliferation through the transcriptional regulation of target genes such as the cell cycle regulator cyclin E and the cell death inhibitor diap1. The mammalian homologues of Hpo, Sav, Wts and Yki constitute an analogous kinase cascade and that the mammalian Hippo pathway plays a conserved role in organ size control. Most recently, we have discovered Kibra (Kbr) as a novel tumor suppressor that functions together with Merlin (Mer) and the related FERM domain protein Expanded (Ex) to regulate the Hippo kinase cascade. Since signaling events upstream of Hpo still remain poorly defined, our identification of this novel protein complex provides new opportunities to investigate this less understood aspect of the Hippo signaling pathway. In the coming project period, we propose to build on these findings to further elucidate the composition, function and regulation of the Hippo pathway, through the following lines of research. First, we aim to define a complete Hippo signaling pathway that relays information from the extracellular milieu to Yki phosphorylation by conducting a genome-wide RNAi screens and genetic screens for additional components of the Hippo pathway. Second, we will identify the missing DNA-binding transcription factor(s) that regulates Hippo target gene transcription, since our previous characterization of Sd and Yki suggests that Yki may partner with additional DNA-binding transcription factors to regulate the expression of Hippo target genes. We will test this hypothesis by conducting systematic protein-protein and protein-DNA interaction screens. Lastly, we will investigate the molecular and cellular mechanisms by which the Kbr-Ex-Mer complex functions within the Hippo pathway. Besides revealing fundamental mechanisms of eye development, the proposed studies will have general implications for the development of other tissues. PUBLIC HEALTH RELEVANCE: The proposed studies will not only allow us to elucidate the basic molecular mechanism that regulates retina cell number, but also provide general insights into how cell number is determined in other organs during animal development and how aberrant regulation of this process could lead to tissue atrophy or tumorigenesis. Such insights may facilitate the therapeutic interventions of relevant human diseases, including diseases of the retina.

Public health relevance
Project Narrative The proposed studies will not only allow us to elucidate the basic molecular mechanism that regulates retina cell number, but also provide general insights into how cell number is determined in other organs during animal development and how aberrant regulation of this process could lead to tissue atrophy or tumorigenesis. Such insights may facilitate the therapeutic interventions of relevant human diseases, including diseases of the retina.